Automatic Control of Standing Balance and Gait with Implanted Neuroprostheses

The overall goal of the proposed research is to develop a new control system to
maintain standing balance at various task-dependent, user-specified postures, and
enable dynamically stable reciprocal stepping in persons paralyzed by spinal cord
injuries (SCI) with an implanted motor system neuroprosthesis (NP) and prepare for
ensuing home-going trials and clinical dissemination. A system that automatically
modulate neural stimulation to maintain standing balance and generate successive
reactive steps to achieve effective reciprocal gait will be translated to the Networked
Neural Prosthesis System (NNPS). Each module of the NNPS contains internal sensors
that would eliminate the need for external devices and cabling. The project will
determine the feasibility of a safe and functional LE motor system NP that can be
realized with a fully implantable system suitable for home and community use.
Aim 1 will determine effective and efficient methods to estimate whole body center of
mass (CoM) kinematics and evaluate suitability for real-time control with the NNPS. This
will entail estimating CoM from external sensors attached to able-bodied volunteers and
current recipients of standing and stepping NPs at the anticipated surgical location of
modules of the NNPS. We will implement our existing biologically-inspired standing
balance and stepping controllers with NNPS simulated signals in volunteers with SCI
and evaluate their performance in response to internally generated and externally
applied disturbances. Aim 2 will extend the control system to automatically generate
successive reactive steps, and enhance inter-limb loading and dynamic balance during
stance phases of gait. A system that enables forward progression of the CoM to
maintain balance in the medio-lateral direction, optimizes forward propulsion, and
ensures proper swing limb foot placement during successive reactive steps will be
developed in simulation, and experimentally validated with able-bodied volunteers and
recipients of implanted NPs. Our existing control systems for bipedal stance and
reactive stepping will be adapted to maintain balance and achieve smooth translation of
CoM during walking and recent development in the field of walking robots will be
applied. We expect that walking with the extended biologically-inspired control system
will be smoother, more efficient and more resilient to potential destabilizing influences
than conventional pre-programmed stimulation. Aim 3 will create the resources
required to translate the standing and walking controllers to the new NNPS platform in
preparation for clinical implementation and ensuing home-going trials. Work will
develop, document and verify operation of lower extremity-specific software and
clinical/user interfaces to the NNPS. We will prepare and submit an Investigation Device
Exemption to the USFDA for a new feasibility study of LE applications of the NNPS in
preparation for ensuing clinical trials of safety and effectiveness.

Public health relevance
This project will determine the feasibility of a new biologically-inspired control system for implanted motor neuroprostheses (NP) that automatically maintain standing balance and generate successive reactive steps based on estimates of global center of mass (CoM) in individuals with spinal cord injuries (SCI). Existing NPs for standing after SCI supply continuous stimulation to the paralyzed muscles and restrict users to a single, pre-defined posture. We will apply advanced biomechanical modeling and computer simulation techniques to develop new control elements that a) accurately estimate the users' whole body CoM kinematics in real-time, and b) enable users to elicit dynamically stable successive steps to achieve effective reciprocal gait. We will also create the resources required to translate these advanced control systems to the Networked Neural Prosthesis System (NNPS) platform in preparation for clinical implementation and ensuing home-going trials. Performance of the resulting control systems will be determined experimentally in 10 volunteers with motor complete SCI. The outcome will define new interventions that provide the ability to assume task-dependent, user- specified postures, enable dynamically stable reciprocal stepping, and enhance the safety of fully implantable standing systems for use in the home and community.